Developmental and Mentoring Core

ABSTRACT: DEVELOPMENTAL CORE
The UNC-Malawi-South Africa Cancer Consortium (UMSACC) seeks to train the next generation of
practitioners and leaders to conduct high-impact research on HIV-Associated malignancies in low- and middle-
income country (LMIC) settings. Our proposed Developmental and Mentoring Core (Developmental Core) will
be embedded within the existing, highly successful, NIH-supported research training infrastructure that UNC
has established with LMIC partners in Malawi and South Africa over the past two decades. Despite our many
training successes, a central problem for investigators in LMIC settings is the lack of dedicated career
development support and protected time to conduct research and compete for independent funding. We
propose to address this problem through a comprehensive approach to training and mentoring early-career
cancer researchers. First, we will create a strong mentorship program to support the development of at least
nine African and U.S. investigators. Mentorship will focus on design and implementation of hypothesis-driven
research, manuscript writing, and development of grants. Second, we will leverage ongoing leadership
development programs in Malawi and South Africa to develop a strong pool of research supervisors/mentors
for medical and public health trainees. Third, we will provide at least 15 mentored research grants to promising
African and U.S. investigators to support hypothesis-driven research projects and/or obtain preliminary data for
larger grant applications related to HIV-associated malignancies.

Public health relevance
PROJECT NARRATIVE: DEVELOPMENTAL CORE The Developmental and Mentoring Core of the UNC-Malawi-South Africa Cancer Consortium (UMSACC) aims to develop Malawian, South African, and U.S. investigators and build capacity to conduct high quality HIV- associated cancer research in Africa. The Core’s focus is to provide mentorship in design and implementation of hypothesis-driven research, manuscript writing, and development of grants.